Molecular MR-PET to characterize malignant transformation and identify therapeutic vulnerabilities in human IDH-mutant gliomas

PROJECT SUMMARY/ABSTRACT
The World Health Organization (WHO) classification of gliomas has been steadily shifting from a histological
classification towards a molecular classification. For example, isocitrate dehydrogenase (IDH) mutational status
is a critical feature of the recent 2021 WHO classification. Compared to IDH-wild-type (IDH-wt) gliomas, IDH-
mutant (IDH-m) gliomas have distinct clinical characteristics such as accounting for most low-grade gliomas
(LGGs; grade 2), having better prognosis, growing slower, and affecting a younger patient population compared
to IDH-wt gliomas. However, all WHO grade 2 IDHm gliomas are expected to eventually become malignant
higher-grade (WHO grades 3-4) gliomas in a process known as malignant transformation. Upon malignant
transformation, patients with IDHm gliomas have a significantly worse prognosis. Thus, early, non-invasive
imaging biomarkers of IDHm glioma malignant transformation may allow for earlier identification of treatment
failure and appropriate therapeutic interventions.
Magnetic resonance imaging (MRI) is critical for the management of patients with IDHm gliomas. Currently,
identification of malignant transformation in patients with IDHm gliomas involves the emergence of contrast-
enhancing areas on T1-post-contrast MRI in previously non-enhancing grade 2 gliomas. However, advanced
MRI biomarkers sensitive to acidity, perfusion, and cellular density may provide earlier identification of the tumor
microenvironment changes associated with malignant transformation and earlier identification of treatment
failure. Furthermore, combining our lab’s pH-sensitive MRI with metabolic positron emission tomography (PET)
imaging may yield deeper insights into the tumor microenvironment, particularly for metabolic shifts associated
with malignant transformation and new IDH inhibitor targeted therapies that inhibit the mutant IDH enzyme. As
a result, this proposal seeks to identify molecular MR-PET biomarkers associated with malignant transformation
and successful IDH inhibition of IDHm gliomas.
In Specific Aim 1, we will establish a sequential order of advanced MRI biomarkers in IDHm gliomas
undergoing malignant transformation using pH-sensitive, perfusion, diffusion, and anatomical MRI and then
validate MR-PET biomarkers of IDHm gliomas with histopathological markers from targeted surgical biopsies. In
Specific Aim 2, we will utilize pH-sensitive MRI and PET to evaluate metabolic perturbations in IDHm gliomas
following successful IDH inhibitor therapy. The proposed studies may improve IDHm glioma management by
establishing imaging biomarkers of malignant transformation and successful IDH inhibitor treatment response.

Public health relevance
PROJECT NARRATIVE Isocitrate dehydrogenase (IDH)-mutant gliomas have distinct metabolic characteristics and therapeutic vulnerabilities. However, advanced imaging biomarkers of IDH-mutant glioma remain limited for malignant transformation and new IDH inhibition therapy. Our proposed studies will utilize molecular MR-PET imaging to identify imaging biomarkers that could improve the clinical management of IDH-mutant gliomas.